Personalized Deep Brain Stimulation for Epilepsy

PROJECT SUMMARY/ABSTRACT
Epilepsy impacts 1% of the US population with a third experiencing drug-resistant epilepsy. FDA-approved
treatments like anterior nucleus of the thalamus deep brain stimulation, and thalamic responsive
neurostimulation show great promise, however, rarely achieve seizure freedom. Thalamic neuromodulation is
limited by a generic approach to electrode targeting and stimulation parameter selection, which does not
account for highly variable patient specific seizure network (SN) structure and excitability. Our hypothesis
is that optimal thalamic neuromodulation requires a highly personalized approach, with SN-specific electrode
targeting, and short-latency biomarkers for efficient data-driven optimization of stimulation
parameters. The objectives of this research are to 1) delineate and measure precise causal connections within
brain networks (effective connectivity) using single pulses of stimulation delivered through stereotactic
intracranial EEG (sEEG) leads, and 2) characterize thalamic neuromodulation induced changes in network
excitability using short-latency electrophysiology biomarkers.
Here, we will employ clinical intracranial stereotactic EEG (sEEG) that includes a thalamus electrode,
and single pulse and repetitive high frequent stimulation to map, characterize, and modulate brain networks.
We aim to 1) map thalamocortical effective connectivity using single pulse electrical stimulation during sEEG
(3-4 thalamus stimulation sites, and approx. 200 recording locations per individual); 2) characterize the
temporal structure of thalamocortical evoked potentials in non-seizure and seizure networks using a data-
driven computational machine-learning approach (identify specific features that distinguish normal from seizure
networks); and 3) characterize thalamic high frequency stimulation induced changes on network excitability,
and the timescales of effects. This work aims to develop a highly personalized approach to thalamic
neuromodulation, with seizure network specific electrode targeting and data-driven stimulation parameter
optimization. Lastly, we will use an ethics framework to gather and integrate patient perspectives on precision
neuromodulation to ensure that efforts align with patient priorities.
My career development objectives are to gain expertise in: 1) multimodal brain network mapping,
integrating electrophysiology and imaging techniques (SA1), and 2) advanced signal processing and machine-
learning methods for data-driven feature classification (e.g. distinguish normal from seizure networks (SA2);
quantify stimulation induced changes in excitability (SA3)). I will develop independent expertise with flexible
neuromodulation systems (g.tec, NeuraLynx, Cadence) (SA1, 3). Further, I will pursue comprehensive training
in translational research, clinical trial conduct, and grant writing, equipping me for the shift to an independent
research career. This career development award is pivotal for my progression towards independent RO1
funding and provides the foundation for clinical trials in personalized thalamic neuromodulation for epilepsy.

Public health relevance
PROJECT NARATIVE Epilepsy affects 1% of the U.S. population, with a third facing drug-resistant forms; while thalamic deep brain stimulation and other neuromodulation therapies are FDA-approved, they seldom achieve complete seizure control, and are limited by a generic approach. We posit that seizure control can be significantly enhanced by a personalized neuromodulation strategy that involves seizure network (SN)-specific electrode placement and the use of short-latency biomarkers for data-driven assessments of stimulation effects. This proposal employs stereotactic EEG with thalamic electrodes and brain stimulation techniques to map, characterize, and modulate brain networks, to advance a highly personalized approach to electrode placement and parameter optimization for epilepsy neuromodulation.